Leica Stellaris 8 Confocal Microscope

Conventional confocal microscopy is a powerful tool for special-temporal cellular and tissue
imaging, typically with up to four fluorophores. Recently, there has been an increasing demand
for multiplex, high-resolution analysis. However, with most currently available microscopes it is
technically impossible to detect fluorophores in the near-infrared (NIR) range, thus limiting the
multiplexing capability. The enhanced detection is required not only for detection in the near-
infrared (NIR), but also because this allows the use of directly conjugated antibodies when the
choice of species in which any primary antibodies were generated is limited. Establishing a user-
friendly multiplex imaging system to complement genome-wide, next-generation sequencing
analysis is an unmet need. An additional limitation of conventional confocal microscopy is its
resolution. Several recently developed confocal scanning microscopes are beginning to meet this
need by combining superior detectors and advanced computational deconvolution to enhance
both multiplexing options and resolution. Both multiplexing capability and resolution are
particularly imperative for the major users on this proposal who focus on developmental and stem
cell biology to deepen our understanding of human disease and develop innovative treatments.
We therefore propose to acquire a Leica Stellaris 8 microscope that allows multiplexing by
providing excitation and enhanced detection in the NIR, as well as computational super-
resolution.

Public health relevance
Current biomedical research increasingly requires sophisticated imaging of cell cultures, including organoid cultures, and of developmental processes. We propose to acquire a novel microscope, that is uniquely capable to rapidly image such structures with high resolution and for multiple markers.